ApOE effects on neuron signaling and function via ApoER2

DESCRIPTION (provided by applicant): APOE is the strongest genetic risk factor for Alzheimer's disease and many of its actions in the brain are mediated by specific apoE receptors. Over the past several years, we have defined various signaling roles for apoE and apoE receptors in the brain, and examined how they affect neuronal physiology and animal behavior. In this proposal, we are focusing on one of the most interesting synaptic apoE receptors, ApoER2, and its mechanism of function as a synaptic signaling molecule. Furthermore, we are addressing how the three human apoE isoforms differ in their interactions with ApoER2, using APOE targeted replacement mice. This project is a collaboration between two investigators at two sites, to make use of common interests in ApoER2 signaling and diverse experimental techniques. By conducting both in vitro and in vivo experiments, we will be able to test the in vivo relevance to in vitro findings and design in vitro experiments to define mechanisms for in vivo findings. There are four specific aims; the first three examine the neuronal signaling functions of apoE isoforms via ApoER2; the last one examines how those functions may contribute to pathogenic processes of neurodegeneration. 1. We will determine the in vivo effects of the three human apoE isoforms on neuronal structure and synaptic function; 2. We will define mechanisms of ApoER2 effects on neuronal signaling in vitro; 3. We will define how ApoER2 affects neuronal signaling in vivo; and 4. We will translate these basic findings into two approaches to protecting against synaptic loss in models with Alzheimer's disease pathological changes. These connected and complementary aims will allow us to define important roles of apoE isoforms in normal neuronal function, which may contribute to the associated risk of AD. These experiments also address new functions of apoE receptors in neuronal signaling, defining mechanisms by which these receptors alter synaptic function. They also explore the role of receptor clustering in normal receptor signaling mechanisms. Finally, they will test two important hypotheses about how APOE genotype alters the risk of Alzheimer's disease, translating preliminary findings about JNK activation and ApoER2 receptor clustering into approaches to prevent the synaptic dysfunction associated with neurodegeneration.

Public health relevance
PUBLIC HEALTH RELEVANCE: Alzheimer's disease affects over 5 million people in the USA already, and the numbers will triple in 40 years giving the increasing numbers of aged citizens. APOE is the strongest genetic risk factor for Alzheimer's disease, influencing over half of all cases, but we do not know how it influences the disease. This proposed research will address the actions of apoE in the brain, and identify ways that it could be affecting Alzheimer's disease. Principal Investigator/Program Director (Last, First, Middle): Rebeck, G. William & Weeber, Edwin J. Alzheimer's disease affects over 5 million people in the USA already, and the numbers will triple in 40 years giving the increasing numbers of aged citizens. APOE is the strongest genetic risk factor for Alzheimer's disease, influencing over half of all cases, but we do not know how it influences the diease. This proposed research will address the actions of apoE in the brain, and identify ways that it could be affecting Alzheimer's disease. PHS 398/2590 (Rev. 09/04, Reissued 4/2006) Page Continuation Format Page __SpecificAimsTextDelimiter__ Principal Investigator/Program Director (Last, First, Middle): Rebeck, G. William & Weeber, Edwin J. 2. SPECIFIC AIMS Apolipoprotein E (apoE) is the strongest genetic risk factor for late-onset, sporadic Alzheimer's disease (AD). Despite this significant finding, the mechanism by which APOE genotype influences an individual's predisposition to AD, and affects normal CNS function, remains unknown. Interesting recent research of apoE actions have established that apoE receptors serve multiple functions in the brain, including neuronal signaling important for synaptic plasticity and memory formation. This correlation between the role of apoE in AD memory loss and its role in synaptic function is interesting, particularly in the light of recent evidence that APOE genotype affects normal brain function in mice and in humans. We hypothesize that apoE is acting as a signaling molecule globally influencing neuronal excitatory responses, affecting apoE receptor signaling capabilities in an isoform specific manner. We hypothesize that alter synaptic function. In this application, we are combining the expertise of two labs that have defined many functions of apoE receptors in the brain, specifically identifying the receptor ApoER2 as a critical post-synaptic modulator of neuronal signaling (Beffert et al., 2006; Beffert et al., 2005; Christie et al., 1996; Clatworthy et al., 1999; Hoe et al., 2006a; Hoe et al., 2005a; Hoe et al., 2006b; Hoe et al., 2008; Hoe et al., 2006c; Hoe et al., 2006d; Hoe and Rebeck, 2005, 2008a, b; Qiu and Weeber, 2007; Qiu et al., 2006c; Rebeck et al., 2006; Weeber et al., 2002). We are also defining the mechanism of ApoER2 signaling using a multi-disciplinary methodology utilizing the strengths of our two labs in biochemistry, cell biology, electrophysiology and animal behavior. By taking these approaches, we will be able to test whether in vitro findings of apoE functions are relevant in vivo and test mechanisms of interesting in vivo findings in controlled in vitro paradigms. We have indicated which lab will take responsibility for which specific subaims, but there will continue to be collaborations at all levels of these experiments. Specific Aim 1: Determine the role of apoE isoform-dependent actions on synaptic function. ApoE targeted replacement (TR) mice express each of the three human apoE isoforms under the endogenous murine promoter. These animals are ideal for direct neurobehavioral comparison of the effects of specific apoE isoform expression and are nicely suited for experimental design to determine the mechanisms underlying apoE isoform-dependent changes in synaptic function. 1A. Determine the effect of apoE isoforms on dendritic spine and synapse formation in vivo (Rebeck). We will examine the morphology of hippocampal neurons using Golgi and fluorescence-based stains in order to determine whether deficits in structures of neurons in APOE4 TR mice contribute to the observed deficits in synaptic function and behavior. 1B. Determine the mechanism of apoE isoforms effects on NMDA receptor modulation (Weeber). We will examine mechanisms to define whether APOE genotype affects composition of synapses and the regulation of receptor subtypes. 1C. Determine if apoE isoforms alter intracellular calcium influx is single neurons or neuronal networks (Weeber). We will examine the entire hippocampal region to define whether APOE genotype alters calcium homeostasis due to our observed changes in excitatory synaptic functions. Taken together with sub-aims 1A and 1B, this Specific Aim will lay the ground work for interpretation and evaluation of data obtained in the successive Specific Aims. Specific Aim 2: Determine the role of ApoER2 in apoE isoform-dependent changes in signal transduction and synaptic function. For several years, the Rebeck and Weeber labs have independently studied aspects of ApoER2 signaling, defining important interacting proteins. Based on Preliminary data, we hypothesize that some of the effects of APOE genotype observed in Aim 1 occur via interactions with ApoER2. 2A. Test how the absence of the alternatively spliced cytoplasmic domain of ApoER2 alters apoE isoform-dependent synaptic changes (Weeber). A unique cytoplasmic domain in ApoER2 is alternatively spliced and interacts with several specific adaptor proteins. We will test the importance of this domain in synaptic structure and signaling. 2B. Determine whether ApoER2 clustering is necessary for ApoE isoform effects on synaptic signaling or spine formation (Rebeck). Several years ago, we published that clustering of apoE receptors is important to intracellular signaling, but it remains undefined how this clustering promotes signal transduction across the cell membrane. This aim will develop new resources in addition to those developed previously to examine how clustering of ApoER2 is involved in synaptic function. 2C. Determine whether interactions between ApoER2 and PSD-95 are necessary for apoE isoform effects on synaptic signaling or spine formation (Rebeck). We have found that the synaptic adaptor protein PSD- PHS 398/2590 (Rev. 09/04, Reissued 4/2006) Page Continuation Format Page Principal Investigator/Program Director (Last, First, Middle): Rebeck, G. William & Weeber, Edwin J. 95 interacts with the cytoplasmic domain of ApoER2 and we will test the hypothesis that interactions between ApoER2 and PSD95 promote synaptic function. Specific Aim 3: Determine how apoE isoforms alter ApoER2 signaling in vivo. The previous aims define signaling and morphological effects of apoE through interactions with ApoER2. This aim will address the in vivo significance of these findings, using assays in whole animals, brain slices, and primary neurons. 3A. Determine if apoE isoforms alter intracellular signaling cascades through ApoER2 (Weeber). We will test whether there are changes in apoE signaling via ApoER2 using ApoER2 knock-out mice, examining both ERK and JNK signaling processes. 3B. Determine the role of ApoER2 in apoE isoform-dependent modulation of NMDA receptor conductance (Weeber/Rebeck). We will test whether differences in APOE effects on synaptic function correlate with in vivo changes in NMDAR activity and phosphorylation. Specific Aim 4: Determine whether apoE receptor activation protects against AD-associated pathological changes. The earliest deficit in AD brains is thought to be the loss of synapses. We hypothesize that APOE ε4 genotype predisposes to synaptic dysfunction, and we have developed two translational approaches to reversing effects we have already observed for APOE ε4 effects on neurons in vivo. 4A. Determine if JNK inhibition alters neuronal structure and function in the APOE TR mice (Rebeck). We will use two JNK inhibitors to reverse the overactivation of JNK in APOE4 TR mice, and test whether JNK inhibition leads to increases in APOE expression and protection against synapse loss. 4B. Determine if JNK inhibition alters AD pathological changes in an AD mouse model (Rebeck). We will analyze a model of AD to test whether JNK inhibition counters amyloid deposition, tau phosphorylation, or glial inflammation. Specific Aim 4C. Determine the role of ApoER2 in the disruption of synaptic function in an AD mouse model (Weeber). Building on previous aims, we will test whether the specific activation of apoE receptors reverses effects on synapse loss. Specific Aim 4D. Determine the role of ApoER2 in the disruption of learning and memory in an AD mouse model (Weeber). We will examine whether changes that we observe pathologically correlate with changes in animal behavior, allowing us to test whether any therapeutic benefit may be obtained from the observed levels of protection against any pathological changes (e.g., synapse loss, tau phosphorylation, glial inflammation). PHS 398/2590 (Rev. 09/04, Reissued 4/2006) Page Continuation Format Page